Imaging the Neurobiology of a Behavioral Treatment for Cocaine Dependence

DESCRIPTION (provided by applicant): Previous studies of cocaine dependence have sought to identify predictors of a positive treatment response, and have focused on personality traits, cognitive ability, and co-morbidity. In the first cycle of this award, our group investigated the rle of neurochemistry in success and failure to respond to a well-established behavioral treatment for cocaine dependence. Using Positron Emission Tomography (PET) and the radiotracer [11C]raclopride, we measured both D2/3 receptor binding potential (BPND) and stimulant-induced [11C]raclopride displacement (ΔBPND) in treatment-seeking cocaine dependent subjects. The scans were performed prior to subjects receiving a behavioral treatment that uses positive reinforcement (voucher incentives) for 24 weeks. The results showed that both PET outcome measures were increased in the subjects who responded to treatment compared to those who relapsed. In addition, both BPND and ΔBPND did not differ between the treatment responders and a group of matched healthy controls. Thus, these results suggest that low dopamine transmission is associated with a greater likelihood of a poor treatment response, and that treatment responders may have intact dopamine signaling. The goal of this competing renewal is to use imaging to further expand our understanding of the deficit of dopamine transmission seen in treatment non-responders. The first goal will be to replicate the finding seen in cycle one with [11C]raclopride and a stimulant challenge. In order to better characterize the deficit in dopamine signaling, PET scans will be also performed with the radiotracer [18F]DOPA, which provides a measure of pre-synaptic dopamine synthesis and storage. In addition, fMRI scans will be performed to probe the reward system. Combined, these imaging studies will provide an understanding of the differences in striatal dopamine transmission and activation of reward pathways that differentiate cocaine dependent subjects who respond to treatment compared to those who relapse, and can be used to direct future treatment development.

Public health relevance
PUBLIC HEALTH RELEVANCE: Since some participants with cocaine dependence respond to treatment, while other do not, the goal of this study is to better understand the signaling in the brain that is associated with this difference. Using functional neuroimaging, our goal is to study the neurochemistry, specifically dopamine transmission, in cocaine dependent subjects who do not respond to a well- established behavioral treatment. This data can then be used in future studies that develop treatments for this disorder. __SpecificAimsTextDelimiter__ Imaging the Neurobiology of a Behavioral Treatment for Cocaine Dependence 2. Specific Aims Although cocaine dependence is often a refractory disorder with a high risk of relapse, some cocaine dependent patients respond to treatment and recover. In the first cycle of this award, we completed a study that showed differences in the neurobiology of cocaine dependent participants who respond to treatment and those who relapse 5. In that study, cocaine dependent subjects were scanned with the Positron Emission Tomography (PET) radiotracer [11C]raclopride and a stimulant challenge to measure two parameters of striatal dopamine transmission: D2/3 receptor binding and stimulant- induced dopamine release. Following the scans, subjects were enrolled in treatment using positive reinforcement (voucher incentives) combined with the community reinforcement approach 6,7. The results showed that both imaging measures were reduced in the volunteers who failed to respond to treatment compared to those who experienced a positive treatment response. These findings show that striatal dopamine transmission is associated with success or failure to respond to a well-established behavioral treatment for cocaine dependence. Our goal in this competing renewal is to expand upon this finding to deepen our understanding of the mechanism behind blunted dopamine transmission and relapse. Using a combination of PET and functional magnetic resonance imaging (fMRI), we will perform scans that image dopamine transmission, measured as D2/3 receptors, dopamine release, and pre-synaptic dopamine synthesis/storage, and Blood Oxygen Level Dependent (BOLD) striatal activation in response to reward. Specific Aim 1. We will test the hypothesis that blunted dopamine transmission in the limbic striatum is predictive of treatment response in cocaine dependent volunteers. We will seek to replicate our previous finding in a second, larger cohort of cocaine dependent subjects. Dopamine signaling will be measured with the PET radioligand [11C]raclopride and a stimulant challenge, to measure baseline D2/3 receptor binding and stimulant-induced dopamine release. Following the PET scans, participants will be provided with 6 months of behavioral treatment using contingency management (with voucher incentives) combined with the community reinforcement approach. Our hypothesis is that subjects who respond to treatment will have higher measures of both D2/3 receptors and dopamine release compared to subjects who fail to respond and relapse. Specific Aim 2. We will test the hypothesis that blunted pre-synaptic dopamine synthesis and storage in the limbic striatum is associated with a poor treatment response. Striatal uptake of the radiotracer [18F]DOPA is a marker of pre-synaptic nerve terminal function and reflects dopamine synthesis and storage capacity. Uptake of this radiotracer has been shown to be modulated by treatment in studies of schizophrenia, suggesting that it may serve as a biomarker for treatment response 3. In this study, we will test the hypothesis that [18F]DOPA uptake is lower in subjects who relapse during treatment compared to those who respond. A group of matched control subjects will be included for comparison of both the cocaine dependent subjects who respond to treatment and those who do not. Specific aim 3. Using the Monetary Incentive Delay (MID) Task with fMRI, we will test the hypothesis that a poor treatment response is associated with blunted activation of the limbic striatum compared to treatment responders. The MID task was developed to probe the anticipation of positive incentives in the striatum. Previous studies have shown that the MID task reliably produces activation in the ventral striatum, which is thought to correlate with dopamine signaling 8,9. The proposed study will provide the first imaging study using this task in cocaine dependent subjects who receive a voucher-based behavioral treatment. A group of matched control subjects will be also be included for comparison group with the cocaine dependent subjects. Multimodal analysis: All subjects will be asked to participate in the 3 PET scans and the fMRI. Thus, each of these imaging-based measures will be examined individually (for each specific aim), but the study design will also provide a rich dataset that enables an exploration of the relationship among these measures, and how they possibly interact in predicting response to treatment.